ShEEP Request for a Confocal Laser Scanning Microscope

The goal of this application is to obtain funding to acquire a Zeiss Confocal Laser Scanning Microscope (LSM)
980 for use by several research investigators at the VA Nebraska-Western Iowa Heath Care System (VA-NWI)
in Omaha, Nebraska. There is a long history of strong and interactive collaborations at VA-NWI, in areas
encompassing obesity, diabetes and other metabolic diseases, nonalcoholic and alcoholic liver disease, chronic
lung disease, and reproductive health. Purchase of the confocal laser scanning microscope (LSM), a
fundamental technology relevant to many disciplines, will further enhance collaborations within VA-NWI and with
collaborators. We are requesting this specific system because it features enhanced detection capabilities,
automated target identification and deconvolution capabilities that boost the resolution beyond that of
conventional LSM microscopes. In addition, the LSM is capable of a wide range of detection modalities including
brightfield and multiple fluorescent wavelengths, essential for our diverse users. We propose two Aims:
Aim 1: To purchase and maintain a Zeiss Confocal Laser Scanning Microscopy System for major use by VA-
funded researchers.
Aim 2: To promote scientific discovery and collaboration for VA researchers.
We provide a detailed plan for daily operation and supervision, user training and education, administrative
oversight through the formation of an Oversight Committee, fee structure for long-term sustainability, and
evaluation for program enhancement. No capability for confocal LSM currently exists on-site at VA-NWI.
Obtaining such a system to be housed at VA-NWI will create new research capability for our VA researchers,
and thus significantly enhance research capacity for both VA investigators and their collaborators. Proposed in
this application (see Table 1) are 9 Major VA Users who each have active VA I-01, RCS or CDA awards currently
supporting their research, and 1 Minor VA User who does not currently have VA funding. Our overall objective
with the acquisition of the Zeiss Confocal Laser Scanning Microscopy System is to expand the research
capabilities and create new collaborations at VA-NWI that result in novel discoveries specifically applicable to
solving the health problems facing our Veterans. This technology, new to our Station, will significantly advance
our capabilities as the system is widely applicable to preclinical research applications in a variety of diseases
impacting Veterans, including metabolic diseases such as obesity and diabetes, alcoholic and nonalcoholic liver
disease, pulmonary disorders, and reproductive health. The flexibility of the system, the diversity of 8 highly
collaborative investigators, and the experience of the Oversight Committee should enable us to achieve our
goals. This state-of-the-art system will promote new research and collaborations at VA-NWI that would otherwise
not be possible.

Public health relevance
This application requests funds to purchase a Zeiss Confocal Laser Scanning Microscope (LSM) 980 The LSM allows for high resolution and super-resolution imaging of biological specimens and will further enhance collaborations within VA-NWI and with collaborators. The system will bring new research capabilities to VA- NWI, and is a flexible system capable of meeting the diverse experimental requirements of all participating Investigators. The device will be used by 9 currently VA-funded Major Users and 1 Minor User under the supervision of an Oversight Committee. The device will significantly enhance the physical research infrastructure at VA-NWI. In doing so, the Zeiss LSM 980 will allow our researchers to perform detailed and quantitative imaging studies in a variety of samples at high resolution, greatly expanding our capabilities. This will, in turn, accelerate and augment preclinical research in areas of critical importance to Veterans health, including metabolic disease, pulmonary disorders, liver disease, and reproductive health.